EVALUATION OF MICROENCAPSULATION AS A MEANS TO ADMINISTER CHEMICALS IN FEED

Microencapsulation is a process for completely enveloping tiny masses of solid particles, or liquid droplets in a protective coating which separates the substance from its environment. The use of microencapsulated chemicals for toxicology studies presents a number of advantages, i.e. it permits testing volatile or chemically-reactive compounds int he animal diet, minimizes problems with palatability, etc. Volatile and/or reactive chemicals have been encapsulated using a starch, gelatin or gelatin/sorbitol matrix and determined to be stable when mixed with rodent feed. Relative bioequivalence in rats of the microencapsulated trichloroethylene compared to the neat test material indicates no significant difference in adsorption after oral administration. Feeding studies using the microencapsulated trichloroethylene, have been successfully completed. Current studies include the demonstration of bioequivalence of microencapsulated 1,1,1-trichloroethane, 2-ethylhexanol, and citral.